COLLEGE ON PROBLEMS OF DRUG DEPENDENCE ANNUAL MTG 1994

The College on Problems of Drug Dependence (CPDD) will hold its 57th Annual Scientific Meeting in Scottsdale, Arizona, June 10 through June 15, 1994. There will be 5 days of scientific sessions which will be made up of volunteer oral presentations, poster sessions, and 11 or 12 timely symposia. There will be a good balance of all fields and topics representing the drug abuse research community. Although final symposia choices will not be made by the Program Committee of CPDD until the fall of 1994, among the list of symposia and chairs that have already been submitted and are under consideration by the Program Committee are the following: "Cannabinoid Receptors and Ligands" - Billy R. Martin, Ph.D. "Interactions Among Opioid Receptor Types" - Frank Porreca, Ph.D. "Drugs of Abuse and the Immune System" - Toby K. Eisenstein, Ph.D. and Herman Friedman, Ph.D. "Molecular Biology of Opioid Receptors" - George Uhl, M.D. "Molecular Biology of Nicotine and other Non-Opioid Receptors" - Leo Abood, Ph.D. "New Medications for Drug Abuse: Preclinical" - Ross Johnson, Ph.D. "New Medications for Drug Abuse: Clinical" - Charles P. O'Brien, M.D., Ph.D. and Thomas Kosten, M.D. "Neuroendocrines and Their Relationship to Addictions" - Theodore M. Cicero, Ph.D. and Mary Jeanne Kreek, M.D. Plenary and award lectures as well as satellite meetings and specialty workshops will complete the program. The Proceedings will be published as an archival NIDA monograph. The monograph will contain symposium papers, plenary lectures, volunteer papers, and reports of the CPDD drug evaluation program. The Proceedings continue to be a valuable compendium of important scientific work in all aspects of drug abuse research. The monograph is mailed to all meeting registrants and to all NIDA grantees. Special attention is given to the needs of young scientists, trainees, and students in the field through a variety of means, including CPDD Travel Awards and NIDA Travel Awards. Such attention is needed to insure a continued cadre of scientists for the field of drug abuse.